Flexible Funding Model Grant ApplicationMichigan Department of Agriculture and Rural DevelopmentFebruary 2018

Project Summary – Abstract RFA-FD-18-001
The Flexible Funding Model - Infrastructure Development and Maintenance for State Manufactured
Food Regulatory Programs (FFM) 5 year grant opportunity focuses on the creation, development and
maintenance of long-term sustainable efforts at the state and local levels to improve capabilities in
human and animal food regulatory programs.
The Michigan Department of Agriculture and Rural Development (MDARD) is the lead state agency
for both food and feed safety with authority to oversee all the segments of the farm-to-fork continuum.
The over-arching goal and vision in Michigan is to maintain a high quality regulatory food program
and continue to grow and enhance its multi-disciplinary, multi-divisional integrated capacity to
respond to food and feed issues within the agency, while improving the effective working relationships
with the FDA-Detroit Office, the Michigan Department of Health and Human Services, Michigan's 45
Local Health Departments, academia and industry stakeholders.
Through the FFM project, Michigan's manufactured food regulatory program standards (MFRPS)
program, Food Protection Task Force, and Rapid Response Team (RRT) program, along with special
projects opportunities would become more cohesive. The grant opportunity would allow Michigan to
improve its capabilities to help advance a national integrated food safety system by continuing to
build and maintain a transferable working model of food regulatory best practices along with the
implementation and integration of advanced rapid response capacities using the Incident Command
System (ICS) and the principles outlined in the RRT Best Practices Manual.

Public health relevance
Project Narrative RFA-FD-18-001 The Flexible Funding Model (FFM) funding support will allow Michigan the opportunity to continue efforts to build an integrated strategy for a sustained, multidisciplinary, multi-agency approach to protect human and animal health through food and feed safety efforts. The Michigan Department of Agriculture and Rural Development (MDARD) has, given the diversity and scope the food and agricultural infrastructure, demonstrated that rapid response capacities for food and feed emergencies are best developed through the active engagement of individuals and task forces with a wide range of expertise in order to protect the public health, environment and the economy. MDARD's conformance with the most current Manufactured Food Regulatory Program Standards (MFRPS) will advance Michigan's efforts to be more consistent and uniform with federal and other state food regulatory programs; maintain high-quality; establish a basis for measuring and improving performance; and direct activities towards reducing food borne illness to further the nationally integrated food safety system.